Engineering a calcium reporter gene for magnetic resonance imaging of neural activity

PROJECT SUMMARY
To encode sensory experience and generate specific behaviors, the mammalian brain relies on functional
coupling between networks of neurons distributed over multiple regions of the brain. Imaging techniques, which
can observe molecular events at a brain-wide scale, are therefore needed to understand how these
interconnected networks function as a whole. Fluorescent genetically encoded calcium indicators (GECIs)
enable optical recording of calcium dynamics (a reliable measure of spiking activity) from well-defined cell types;
but operate over small volumes (~ 1 mm3), limiting access to neural signals in localized neural circuits. Broader
areas (~ 10 x 10 mm2) may be accessed with widefield optical methods; but light scattering limits imaging to sub-
cortical depths in mice. On the other hand, techniques like functional MRI (fMRI) permit activation mapping in
arbitrarily large brain volumes; but the ensuing signal gives only an indirect indication of neural activity based on
localized changes in hemodynamic parameters. Histological techniques like c-fos immunostaining can also
reveal whole-brain activation patterns; but only at a single time point per subject, thus failing to adequately
capture dynamically evolving network properties. These collective limitations create a critical technological gap
for large-scale monitoring of neural activity inside the intact mammalian brain. In this project, we will pilot steps
to address the above challenge by developing genetic tools for imaging calcium with MRI; and we will examine
their ability to faithfully monitor calcium dynamics in cultured neurons. The proposed sensors will be based on a
manganese-binding protein class known as calprotectin, which we introduced in 2021 as the first protein-based
MRI sensor for calcium. These first generation sensors are responsive to calcium concentrations exceeding 5
μM, which is much larger than the typical dynamic range (0.1-1 μM) experienced in neurons during activity.
Starting with the parental sensor protein and building on a strong set of preliminary data, our goals here will be
to optimize sensitivity for calcium sensing down to the neuronal range (Specific Aim 1), establish methods to
genetically express the sensors in mammalian neurons, examine potential sensor-associated toxicity and take
remedial steps if needed, and finally show that we can use these sensors to dynamically image calcium signals
in neurons stimulated with agonists and optogenetics (Specific Aim 2). The primary outcome of this work will be
the development of new neuroscience tools for directly observing calcium dynamics, while combining brain-wide
access with all the advantages of genetic encoding, including cell-specific targeting, long-term expression, and
access to a wide array of neuroscience methods ranging from axon-tracing and BBB-crossing viruses to
transgenic animals. The work here will thus set the stage for previously impossible in vivo studies on identifying
functionally coupled networks involved in everything from learning to executive control and decision making, as
well as how these connections are modified in disease states.

Public health relevance
Project Narrative The proposed research will develop a genetically engineered calcium indicator (GECI) for magnetic resonance imaging (MRI). This reporter will be optimized by protein engineering for high sensitivity over the neurobiological range of calcium concentrations; and validated in cultured neurons by testing their ability to image calcium dynamics evoked by chemical agonists and optogenetic modulation. In the future, this technology will open new avenues for fully noninvasive, large-scale imaging of brain activity with cell-type resolution in mice, rats, and potentially larger animal species.